Methods for quantifying selection in evolving populations

PROJECT SUMMARY
Understanding selection in complex evolving populations is a common theme across the biomedical sciences.
Examples include the characterization of driver mutations that lead to cancer, pathogen evolution to escape
human immune responses, and the growth of antibiotic-resistant bacteria. Recent experimental advances have
substantially increased the availability of temporal genetic data, which could be exploited to detect selection with
greater accuracy and precision. However, inferring selection from temporal genetic data remains technically
challenging. The central goal of my research is to develop and apply efficient computational and statistical
methods to quantitatively describe evolutionary dynamics, including the role of selection in evolution. Drawing
on novel approaches derived from statistical physics, we will develop robust, scalable, and interpretable methods
to infer the fitness effects of mutations from temporal genetic data, accounting for features such as genetic
linkage, epistasis, and time-varying selection. These methods will be integrated into a software package in order
to make them more widely accessible to the community. We will focus on two specific applications: 1)
investigating the evolution of human immunodeficiency virus (HIV)-1 to evade adaptive immune responses, a
prototypical example of rapid and complex evolution, and 2) interpreting massively parallel assays of protein
function. Our research program will create new tools for understanding complex evolving populations and apply
them to elucidate host-pathogen coevolutionary dynamics and to improve widely used high-throughput
experimental techniques.

Public health relevance
PROJECT NARRATIVE Evolution is central to many public health challenges, from the development of cancer to immune evasion and drug resistance in infectious pathogens. Robust methods are needed to translate genetic data into actionable information that can be used to improve treatment. This project will develop new computational methods to quantitatively assess complex evolutionary processes, with applications that will improve our understanding of host-pathogen coevolution and the interpretation of high-throughput mutagenesis studies to characterize the relationship between genotype and phenotype.